Center for Appalachian Research in Environmental Sciences-Pilot Project Program (PPP)

PROJECT SUMMARY – Pilot Project Program
The University of Kentucky Center for Appalachian Research and Environmental Science (UKCARES)
Pilot Project Program (PPP) aims to support highly innovative and collaborative research
studies that will enhance the ability to identify and capitalize on the Center’s science themes and
build community-academic partnerships across the translational spectrum. This goal will be
accomplished by providing pilot funds along with guidance and support for innovative, timesensitive
preliminary studies and community projects that improve our understanding of
environmental exposures, human biology, and disease. Specifically, the aims of the PPP are to 1)
support new opportunities for innovative, collaborative environmental health research; 2) enhance
interactions and expand the critical mass of investigators with expertise and experience in multi -
disciplinary, translational environmental health research at UK and in Appalachian communities;
3) provide guidance and support to ensure the success of UK-CARES Pilot Projects; and 4) evaluate
utilization, efficiency, quality, and impact of the PPP. Strong institutional support of the PPP from
UK is a hallmark of our proposal. In fact, UK entities will provide matching funds, representing 37%
of the total funds allocated for pilot projects. The PPP will provide three general categories of pilot
research funding opportunities consistent with the science themes and strategic vision of UKCARES.
First, Pilot grants will generate new preliminary data and support (a) established Center
members to catalyze new research opportunities consistent with Center science themes; (b) nonmember
scientists to expand collaborations and bring new dimensions to the Center; and (c)
creative, early-stage investigators to establish competitive research programs. Second,
Community grants will provide direct support to community organizations with a UK faculty
collaborator to address a priority science theme. Third, Mini grants will foster rapid, time-sensitive
development of, or access to, new and novel technologies as well as community-engaged
research. The PPP will communicate, collaborate, coordinate, and create synergy across Center
cores and programs to ensure that pilot-funded investigators receive the assistance they need to
develop and carry out their pilot projects. The PPP will engage investigators and community
stakeholders, both within UK-CARES and outside the Center, as reviewers and grantees to
address questions related to environmental pathways (e.g., water, air) to exposures, human
biology, and new contaminants and emerging threats. The overall progress of the PPP, and how
effectively it has promoted environmental health research, will be monitored through the existing
tracking and evaluation component of UK’s Center for Clinical and Translational Science, in
coordination with the Administrative Core. Incorporating pilot-funded faculty into the Center will
have a major impact on expanding the ability of our Center to examine important questions related
to emerging environmental health issues and novel technologies, and to bolster the development
of the next generation of environmental health scientists.